SIP24-008 Economic analysis of an evidence-based MEW epilepsy self-management intervention (MINDSET) in community and healthcare settings.

PROJECT SUMMARY/ ABSTRACT
The goal of this 3-year Special Interest Project is to perform intervention implementation costing and cost-
effectiveness analyses (CEA) (cost-benefit, -utility, and -effectiveness) of the evidence-based Managing
Epilepsy Well self-management program, MINDSET, in community and clinical settings, using retrospective
and prospective data. Through goal-based patient-provider-driven Action Planning MINDSET (Management
Information Decision Support Epilepsy Tool) has demonstrated impact in increasing patient epilepsy self-
management (ESM) behaviors and validity in providing recommendations for linkage to salient MEW programs
(PACES, UPLIFT, HOBSCOTCH) and assessment and feedback on patient social determinants of health.
This proposal supports the 2012 IOM report for “development, evaluation, replication, and expanded use of
ESM and educational programs, including MEW Network programs to improve quality of life for PWE” and
multiple Health People 2030 targets to improve health and well-being in people with disabilities, improve
mental health, and increase access to comprehensive, high-quality health care services. The CEA will be
performed as recommended by the task force of experts organized by the U.S. Public Health Service and the
International Society for Pharmacoeconomics and Outcomes Research. This proposal addresses the broader
challenges around understanding financial preparedness and the value associated with interventions to enable
the dissemination and implementation of evidence-based epilepsy self-management programs in clinical and
community settings. As the MEW-EBP evidence base matures there is a need to guide healthcare providers
(HCPs) and decision-makers on the economic feasibility of adopting, implementing, and maintaining these
programs that includes guidance on coding and billing practices to offset implementation costs.
This study aims to:1.) Assess MINDSET intervention implementation costs in community (EFCST, EFTx) and
clinical health care (Kelsey Seybold, Harris Health, UTHealth, Banner, Barrow) settings using retrospective and
prospective data (Year 1) to facilitate financial preparedness for new organizations wanting to implement
MINDSET. 2.) Assess MINDSET cost-effectiveness in the community (EFCST, EFTx) and clinical healthcare
(Banner, Barrow) settings using retrospective and prospective data (Years 2-3) to establish the value
associated with the intervention. 3.) Collaborate with other MEW Network members (Years 1-3). 4.) Contribute
to the annual evaluation report of site-specific activities and network-wide collaboration and disseminate
findings (Years 1-3).

Public health relevance
PROJECT NARRATIVE The University of Arizona and the University of Texas, Houston research teams will collaborate in this innovative study that looks to perform intervention implementation costing and cost-effectiveness analyses (CEA) (cost- benefit, -utility, and -effectiveness) of the evidence-based Managing Epilepsy Well network self-management program, MINDSET, in community and clinical settings, using retrospective and prospective data. This project is significant in providing data for decision-makers regarding the economic feasibility of implementing an ESM evidence-based program (MINDSET) in clinic and community settings.